Developing an exosomic signature of rapidly progressive idiopathic pulmonary fibrosis

PROJECT SUMMARY
Idiopathic pulmonary fibrosis (IPF) is a chronic form of interstitial lung disease with varying rates of disease
progression. A subgroup of patients experience rapid IPF progression characterized by progressive respiratory
failure and premature death. It is critically important to identify patients with rapidly progressive IPF early in their
course to facilitate early initiation of disease-modifying interventions. Current clinical approaches to IPF
prognostication including staging systems that integrate measures of lung physiology have very limited
prognostic discrimination and provide no insights into the pathobiological mechanisms of IPF progression.
Analyses of extracellular vesicles and their miRNA cargo (EV-miRNAs) provide a unique opportunity to improve
both domains by identifying novel biomarkers of accelerated IPF progression and elucidating potentially
modifiable targets for IPF treatment. Recent preclinical studies suggest alterations in plasma EV-miRNAs
precede IPF progression. However, studies in human populations are limited.
In this K23 Mentored Patient-Oriented Research Career Development Award, Dr. Christina Eckhardt will build
upon her prior work showing plasma EV-miRNAs are robust biomarkers of early lung injury and will investigate
the role of plasma EV-miRNAs in IPF progression. The central hypothesis is that adults with rapidly progressive
IPF have unique plasma EV-miRNA signatures that can quantify and predict risk of accelerated IPF progression.
To test this hypothesis, Dr. Eckhardt will cost-effectively leverage three prospective IPF cohorts with ready-to-
use collections of blood draws, lung function data, and respiratory health outcomes data. Dr. Eckhardt will
leverage these existing resources to identify EV-miRNAs that capture and quantify the intrinsic progressiveness
of IPF (Aim 1), derive and validate an EV-miRNA signature that predicts accelerated IPF progression (Aim 2),
and define the relationship between profibrotic gene expression in lung cells and EV-miRNA expression in
plasma to corroborate EV-miRNAs as accessible biomarkers of distinct biological pathways in IPF lungs (Aim
3). To complete these aims, Dr. Eckhardt will receive expert guidance from her renowned mentoring team: Drs.
Ke Cheng (Extracellular Vesicles), Christine Garcia (Interstitial Lung Disease), Elizabeth Oelsner (Respiratory
Epidemiology), and Iuliana Ionita-Laza (Biostatistics). Specifically, Dr. Eckhardt will receive training in (1)
extracellular vesicles and translational research methods, (2) prospective study design and conduct in adults
with interstitial lung disease, (3) advanced statistical modeling, and (4) research dissemination and professional
development. This career development plan will prepare Dr. Eckhardt for a career as an independent academic
clinical-translational researcher who develops novel strategies to improve IPF diagnosis, optimize IPF
prognostication, and deliver precision-guided interventions for adults with IPF.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a chronic form of interstitial lung disease with varying rates of clinical progression, and current clinical approaches to IPF prognostication have very limited prognostic discrimination and provide no insights into the pathobiological mechanisms of IPF progression. Analyses of extracellular vesicles and their miRNA cargo (EV-miRNAs) provide a unique opportunity to improve both domains by identifying novel biomarkers of accelerated IPF progression and elucidating potentially modifiable targets for IPF treatment. The proposed research promises to advance efforts to optimize IPF prognostication, facilitate earlier delivery of disease-modifying therapies for adults with rapidly progressive disease, and develop novel precision- guided interventions for adults with IPF.